A synthetic toolkit for the recombinant production of tyrosine phosphorylated proteins and peptides

Project Summary
Tyrosine phosphorylation (pTyr) is a post-translational modiﬁcation that can regulate protein function and interac-
tions. Tyrosine phosphorylation often becomes dysregulated in cancer and therefore, understanding the effect of
phosphorylation on protein function and within biochemical networks will be paramount to identifying therapeutic
interventions in cancer. Unfortunately, much of tyrosine phosphorylation is referred to as the “dark phosphopro-
teome”, because we either cannot detect it or we do not understand what its role is in regulating proteins and
networks. The dark phosphoproteome exists as a result of limitations in tools for testing and measuring pTyr
within proteins and networks. In previous work, we developed a synthetic toolkit that has superior yields of phys-
iologically relevant tyrosine phosphorylation on proteins of interest, compared to existing approaches. The goal
of this work is to: 1) harden this technology for increased reproducibility and ﬂexibility and 2) extend this technol-
ogy to produce reagents, at a fraction of their current cost, for use in quantitative measurement and monitoring
of phosphotyrosine sites in mass spectrometry-based workﬂows relevant to cancer progression and treatment
response.

Public health relevance
Project Narrative In accordance with the purpose of the NCI RFA-CA-21-004, this project will accelerate basic and applied cancer research through the development of a molecular technology, which will enable rapid advances in the understand- ing of tyrosine phosphorylation – a process consistently dysregulated in human cancers.